Epigenomic regulation of oxidative stress-producing innate immunity in neuroinflammation

PROJECT SUMMARY / ABSTRACT
Oxidative stress is a central part of innate immune-induced neurodegeneration in neurological disorders
including multiple sclerosis (MS). However, the molecular mechanisms regulating oxidative stress gene circuits
to promote neurotoxic immune responses remain poorly characterized. Emerging evidence supports a role for
the epigenome in tightly regulating immune cell gene activity in MS. Yet, the epigenomic landscape and function
in prooxidant, neurotoxic central nervous system (CNS) innate immune cells in MS remains unknown. Thus,
discovery of drugs capable of selectively suppressing immune-driven neurodegeneration has been hindered by
lack of molecular understanding of neurotoxic functions of CNS innate immune cells. The ultimate goal of this
project is to define the regulatory landscape of prooxidant immune cells and identify mechanisms that translate
epigenetic aberrations into innate-immune driven neurodegeneration for devising novel therapeutic interventions
for MS. Our preliminary data discovered a molecular convergence of neurotoxic microglia and peripheral
macrophages to a core oxidative stress gene signature in MS model. By applying an innovative experimental
design with cutting-edge methods, this proposal aims to define the epigenetic and transcriptional components of
oxidative stress-producing innate immune cells in a mouse model of neuroinflammation for MS through unbiased
profiling of the open chromatin landscapes (Aim 1) and histone modifications (Aim 2). These molecular
characterizations will identify key MS-related regulatory elements that will be functionally validated in vitro and
in vivo with CRISPR interference assays (Aim 3). This project will provide a foundational epigenomic outlook on
the molecular circuits governing prooxidant, neurotoxic immune responses in neuroinflammatory disease, and
the research outcomes may reveal candidates for the development of new treatments for innate immune-
mediated oxidative injury in MS and related conditions. The comprehensive training plan will enable the PI to
achieve his career goal of launching a successful independent research laboratory dedicated to studying
epigenomic mechanisms contributing to immune dysfunction in MS for targeted treatments. The MOSAIC UE5
mentoring, leadership, and diversity training will facilitate his transition to independence and enable the PI to
enhance diversity in the biomedical workforce in the R00 phase and beyond. As a mentee in Dr. Katerina
Akassoglou’s laboratory, a leader in neurovascular and immune mechanisms of MS pathogenesis, at the
esteemed academic environment of Gladstone Institutes and University of California, San Francisco, the PI will
obtain new training in functional epigenomics and CRISPR genome engineering during the K99 phase. The PI’s
training and career development will be bolstered through an advisory committee of faculty with related expertise;
and the PI’s participation in didactic activities such as coursework in epigenomics and seminars, will collectively
allow the PI to complete this project and integrate these approaches for making meritorious contributions to the
fields of MS and epigenomics in future independent research.

Public health relevance
PROJECT NARRATIVE Oxidative stress is a common pathological thread in many neuroinflammatory and neurodegenerative diseases, including multiple sclerosis (MS). To date, there are no treatments for the prevention of neurodegeneration caused by innate immune-mediated oxidative injury in MS. The goal of this project is to determine the epigenomic mechanisms underlying oxidative stress gene activity and function in toxic innate immune cells in MS models, which may provide therapeutic candidates for intervention of MS.